TREATING PRETERM INFANTS WITH THYROTROPIN RELEASING HORMONE AND CORTICOSTEROIDS

The Neonatal Satellite Unit protocol investigates the mechanisms of decreased incidence of chronic lung disease in preterm infants treated antenatally with thyrotropin-releasing hormone (TRH) and corticosteroid (CS). It seeks to determine whether antenatal treatment with TRH and CD improves the efficacy of surfactant treatment in infants who develop respiratory distress syndrome.